Clinical Characterization and Biorepository Core

The ORDRCC provides centralization of rheumatic disease research services through mentorship, clinical
data, and biospecimens from ~71,000 patients registered in the managed collections of our Clinical
Characterization and Biorepository Core (CCBC), comprised of comprehensive clinical evaluations linked to
the only known rheumatic-disease-focused CAP-certified biorepository. To date we have granted
investigator access to >103,000 samples and 4.2B data fields (clinical, experimental, immunologic, genetic).
The 1,963 sample/data requests (571 in the past 4 years) have resulted in 445 publications and our 19 new
investigator pilots have helped launch independent careers with their >$60M in external funding. CCBC-
linked projects have achieved unique insights into disease processes, developed novel patient-reported
outcomes and carried out innovative clinical trial designs, tailored for disease states with complex
pathology. Autoimmune molecular phenotypes identified by our investigators are now being applied
prospectively in NIH-funded and pharmaceutical trials, after identifying unique responder populations to
targeted treatments that would have otherwise failed. The foundational goal of the CCBC is to help launch
and support independent research careers by providing advisory clinical personnel and facilities otherwise
inaccessible for many junior investigators and basic scientists. CCBC personnel have mentored or provided
151 IRB-approved study protocols, nearly all new JCI NIH Human Subject sections, patient recruitment
(n=1,282), and more than 66,068 new sample aliquots linked to comprehensive clinical information. The
current proposal responds to progress in advanced phenotyping science and evolving investigator needs by
modeling clinical and translational research informatics and new methods for collecting and integrating
molecular phenotype data with clinical and patient-reported data to facilitate precision medicine. We will
continue to increase our collections in SLE, RA, UCTD, and Sjogren’s while adding new collections,
including an autoantibody positive post-COVID cohort. Aim 1 will continue rheumatic disease clinical
research support for ORDRCC Junior Investigators, Scholars, and Investigators with mentorship and
regulatory assistance in clinical/interventional study design and a Clinical Research Service Unit for patient
identification, recruitment, and clinical characterization. Aim 2 will expand and increase the sophistication of
sample collection, management, SOPs, and Biorepository infrastructure, and support large rheumatic
disease basic/clinical collaborations. In Aim 3 a new CCBC Innovation Hub will pilot new approaches for
diverse patient recruitment, retention, characterization, home monitoring and remote sample collection to
optimize real time access to patient samples and data as disease flares and improves. Aim 4 seeks to
transform patient lives through science-driven clinical trial design that will reduce data complexity and inform
later optimized, individualized treatment selection and guidance for more refined dosing strategies in clinics.